Center of Research Translation on Osteoporosis Bone Anabolic Therapies

Project Summary – Overall
Osteoporosis is a major problem in our aging population. While the pharmacological treatment of osteoporosis
has advanced substantially over the past 2 decades, treatment that can truly reduce the risks of fracture to
youthful levels remains elusive. Bone anabolic therapies (parathyroid hormone receptor agonists
teriparatide/abaloparatide and the anti-sclerostin antibody romosozumab) represent an important component of
our therapeutic armamentarium for this common, costly, serious, and debilitating disease. Without an
optimized ability to stimulate bone formation, cure of osteoporosis for many patients with severe disease will
not be achieved. Notably, the anabolic efficacy of our currently-used agents wanes over time for unknown
reasons. The goal of the CORT is to elucidate mechanisms of action of osteoporosis anabolic therapies, and to
understand why they stop working. In doing so, the CORT will accelerate translation of knowledge to improve
our understanding of osteoporosis pathobiology. To achieve this goal, the overall focus of the CORT is to
define the cellular and molecular mechanisms of action of currently-used osteoporosis anabolic agents in
humans. A highly-collaborative, multi-disciplinary, international network of investigators based at several
Harvard Medical School-based institutions and Imperial College London have come together to tackle this
challenge. In Project 1, investigators will define the effects of romosozumab and teriparatide on skeletal stem
cells including osteoblast progenitors using flow cytometry, single cell RNA sequencing, and histopathology.
Studies will be performed using samples from patients receiving anabolic therapy and in complementary
genetically-modified mouse models where lineage tracing and single cell RNA sequencing can be combined. In
Project 2, investigators will define the effects of romosozumab and teriparatide on osteocytes. Based on
preliminary data, osteocytes can directly regulate bone matrix formation and remodeling, leading to the exciting
hypothesis, tested here in human and mouse samples that anabolic agents impact cortical bone via direct
effects on osteocytic perilacunar remodeling. Projects 1 and 2 will be supported by a highly innovative
Bioinformatics Core that will incorporate cross-species transcriptomics datasets with available human and
mouse genetics in order to develop novel hypotheses, also tested here, regarding genes and gene network
that mediate bone anabolic responses. CORT efforts will be further enhanced by the complementary
experience of investigators in osteoporosis clinical research, bone biomechanics, bone stem cell biology,
osteocyte biology, bone marrow microenvironment investigation, statistical genetics, osteoporosis
epidemiology, and genetic origins of bone disease.

Public health relevance
Project Narrative – Overall Osteoporosis is a major public health problem in our aging population. The over-arching goal of this center of research translation (CORT) is to understand how bone-building osteoporosis medications work in order to develop ‘next generation’ strategies to treat this disease. To accomplish this goal, we will apply cutting-edge methods to study the effects of such medications on key cell types in bone: stem cells and osteocytes.